Determining the role of CD163+ blood monocytes and lung macrophages in Progressive Pulmonary Fibrosis

PROJECT SUMMARY/ABSTRACT
Sarah Holton, MD, PhD plans for a career as a physician-scientist in the fields of human immunology and
fibrotic interstitial lung disease. Support from this K23 Career Development Award will provide necessary
training in development of patient cohorts, statistical approaches, and methods for the analysis of single cell
and spatial transcriptomic datasets. The training plan described will complement Dr. Holton’s basic science
and engineering background and facilitate her transition to independent research. The proposal leverages Dr.
Holton’s unique access to both the Benaroya Research Institute’s expertise in Immunology and Bioinformatics
and the University of Washington’s expertise in lung biology and Interstitial Lung Disease as well as access to
clinical samples and mentorship at both sites.
The proposal focuses on the role of alveolar/interstitial macrophages and peripheral blood monocytes in the
development of Progressive Pulmonary Fibrosis. These patients have limited therapeutic options that do not
improve lifespan, and their 5 year survival is only 50%. It is critical to identify the mechanisms that lead to
development of fibrosis in order to develop therapies targeted to intervene at early disease stages. We
leverage our expertise in isolating and characterizing human alveolar macrophages and peripheral blood
monocytes, an existing pulmonary diseases biorepository that contains paired alveolar, blood, and lung tissue
samples, and recruiting a prospective cohort of patients from the UW Center for Interstitial Lung Disease.
In this patient-oriented research plan, Dr. Holton will use these resources to address her hypothesis that
CD163+ alveolar macrophages and peripheral blood monocytes are associated with the development of
Progressive Pulmonary Fibrosis and have pro-fibrotic transcriptional programs. Dr. Holton will address these
hypotheses through the following three aims: 1) Test for associations between CD163+ alveolar macrophages
and progressive pulmonary fibrosis in patients with fibrotic ILD in existing samples using flow cytometry, 2)
Establish the spatial and transcriptional relationship between CD163+ macrophages and regions of fibrosis in
biopsy samples isolated from patients with early fibrotic ILD using spatial transcriptomics, and 3) Identify how
the peripheral blood CD163+ monocyte population changes over time and how that is associated with PPF in a
prospectively recruited cohort. Dr. Holton will also uncover the potential mechanism in which these cells
contribute to fibrosis using in vitro models. The findings of these studies will have direct patient impact and will
provide Dr. Holton with the infrastructure and skills necessary to submit an R01 proposal by Year 4 of her
proposed K23 funding period. The research outlined in this proposal will serve as the foundation to growing a
rich clinical biobank of samples from patients with ILD so that Dr. Holton can continue her research in defining
the contribution of macrophage and other immune cell populations to fibrotic lung disease.

Public health relevance
PROJECT NARRATIVE Progressive Pulmonary Fibrosis (PPF) is a severe form of Interstitial Lung Disease that has high morbidity and mortality with a 5-year survival of only 50%. There are limited therapies available to patients and it is unclear why some individuals will develop progressive fibrosis while others do not. The primary goal of this research is to identify immune cell populations that cause Progressive Pulmonary Fibrosis in order to develop markers that can predict early fibrosis progression and novel therapies to intervene at the early stage of disease.